Altered Microglia States and Microglia-Endothelial Cell Axis in Relation to White Matter Disease Progression in VCID

PROJECT SUMMARY
Cerebral white matter abnormalities predict the development of vascular cognitive impairment and dementia
(VCID). Vascular mechanisms, including cerebral hypoperfusion, underly white matter abnormalities.
However, the mechanisms leading to white matter dysfunction and cognitive performance remain poorly
understood limiting the development of effective treatments. Using human post-mortem tissues and studies
in animal models, we have shown that key mechanisms that damage white matter include disruption of
microglia homeostasis, endothelial cell (EC) dysfunction, blood brain barrier (BBB) breakdown and chronic
low-grade microvascular inflammation. Our studies now provide compelling support that microglia ‘state’
(abundance/function) influence white matter abnormalities via interactions with ECs. Our emerging data also
show microglia states respond to reduced microvascular cerebral blood flow (CBF) in a spatially-dependent
manner. Bulk analysis of white matter and grey matter-microglia implicates white matter microglial sensitivity
warranting more in-depth investigation of compartment-related diversity. Further our novel data indicate
microglia may be critical regulators of microvascular tone and hemodynamics. We will build on this work to
test the hypothesis that specific regulators of microglia state influence microglia-microvascular EC
homeostasis and the development and progression of WM abnormalities and cognitive deficits in
VCID. Our cross-disciplinary team (Edinburgh, Newcastle, Sussex (UK)) with expertise in neuroimmune
mechanisms, myelin and vascular biology will bridge animal model to patient. We will use specialised
spatial transcriptomic approaches, imaging modalities and computational approaches to provide a
comprehensive insight to the microglial diversity and how it affects microvascular and white matter alterations
in VCID. The following key aims would be undertaken:
Aim 1: To identify microglia-microvascular EC heterogeneity and intercellular communication in relation
to WM abnormalities in human VCID
Aim 2: To determine if specific regulators of microglia state can improve microglia -microvascular EC
homeostasis and prevent WM disease progression in a model of VCID
Aim 3: To provide functional insight to microglia-microvascular interactions, in real time, in relation to
WM disease progression in a model of VCID.
These studies will provide a critical foundation to define how microglia state influences microglia-EC cross
talk and white matter integrity in VCID, also of relevance to Alzheimer’s disease. The goal is to identify novel
immunomodulatory targets for early therapeutic intervention to attenuate cognitive decline.

Public health relevance
PROJECT NARRATIVE Vascular contributors to cognitive impairment and dementia (including Alzheimer’s disease) have a profound societal impact and despite the importance treatment remains limited. Vascular disturbances lead to disconnection and damage of the brains white matter connectivity associated with cognitive impairment. Our evidence suggests that these harmful effects to white matter are mediated by vascular- immune cell alterations and we will aim to study these in detail to provide new information to enable the development of treatments.